Penn Artificial Intelligence and Technology Collaboratory for Healthy Aging

Summary
The overarching goal of the Technology Identification and Training Core of PennAITech is to use
evidence from the literature, stakeholder and expert inputs to identify the technology needs of
older Americans, as well as develop training activities for artificial intelligence (AI) and
technology for scientists, engineers, clinicians, medical professionals, patients, policy makers,
and investors. The Project “Health App Review Tool: Connecting those Affected by Alzheimer’s
to Needed Technology Support” promotes the Technology Identification and Training Core’s goal
of identifying the technology needs of older Americans with Alzheimer’s disease and related
dementias (AD/ADRD) in addition to providing the resources and tools for connecting them to
their technology needs. The project proposes the development of the Health App Review Tool
(HART), a low-burden tool that aids those affected by ADRD who are experiencing barriers to
initial adoption or sustained health app use. HART is a method of scaffolding the success of
smart technology use among individuals affected by ADRD who may have limited technology
literacy while also providing smart technology developers access to end-user feedback and
related guidance so that they may integrate these insights to improve on available/emerging
tools. Ultimately this tool will become integral in helping identify the technology needs of older
Americans with ADRD and guide future direction for selecting technologies for all pilot projects
funded by PennAITech.

Public health relevance
Narrative This project is imperative and supports the over-arching goal of PennAITech’s Technology Identification and Training Core. HART technology will help consumers affected by ADRD navigate and identify their technology needs, while also providing developers end-user feedback to improve current technologies and create new technological advancements.